Mentoring in Translational Research to Prevent Disparities in Childhood Obesity and Cardiometabolic Disease

PROJECT SUMMARY/ABSTRACT
Dr. Anisha Patel is a midcareer pediatrician-researcher at Stanford applying for a K24 Midcareer Investigator
Award in Patient-Oriented Research (POR). Dr. Patel has excellent training in research (public health, health
services research, community-engaged research, health policy). She has built an innovative research program
that leverages community-academic-policy partnerships to prevent racial/ethnic and income-related disparities
in obesity and cardiometabolic diseases funded by federal agencies, foundations, and institutional support.
She also has an extensive history of mentoring in POR, with a particular emphasis on trainees
underrepresented in health fields. As Associate Professor of Pediatrics at Stanford in many formal mentoring
roles and as Director of Community-Engaged Research in Stanford’s Maternal and Child Health Research
Institute, Dr. Patel is poised to mentor early and junior clinician-investigators in translational science. Dr. Patel
is conducting numerous community-engaged studies to prevent racial/ethnic and socioeconomic disparities in
childhood obesity that provide training opportunities for mentees. The first two aims of this application focus on
two R01-funded cluster randomized-controlled trials (CRTs) examining the impact of drinking water promotion
and access on children’s intake of water and sugar-sweetened beverages, and obesity in elementary schools
(Water First, n=1249 students) and childcare centers (Healthy Drinks, Healthy Futures, n=420 children).This
K24 award will leverage these two trials by applying the RE-AIM framework to examine the interventions’
reach, effectiveness, adoption, implementation, cost, and maintenance. The Specific Aims are to: 1) Estimate
the short-term cost, population reach and effectiveness of Water First and Heathy Drinks, Healthy Futures
interventions in increasing water intake, decreasing SSB intake, and preventing overweight, 2) Examine the
impact of the interventions among different subgroups (by age, sex, racial/ethnic background, English
proficiency and acculturation level), and 3) Describe how the impact of the interventions differ by fidelity to the
intervention implementation strategies. These data will be used to translate evidence into practice and adapt
the interventions for “real-world” settings. The research will also provide a platform for training experiences in
conduct of CRTs, community-engaged research, dissemination and implementation science, intervention
development, mixed methods, dietary assessment, and statistical analysis. The award will also allow Dr. Patel
to expand her mentoring of early stage clinical investigators pursing translational POR and support her own
career development in 1) gaining and applying mentorship and leadership skills, 2) building novel research with
multi-disciplinary investigators, and 3) fostering new research expertise in dissemination and implementation
research and economic evaluation at an opportune time in her career.

Public health relevance
PROJECT NARRATIVE Emerging clinician-scientists need translational science training to translate evidence to practices and policies that are critical in improving population health. This K24 award will use the RE-AIM framework to examine the reach, effectiveness, adoption, implementation (fidelity and cost) and maintenance of drinking water promotion and access interventions in schools and childcare centers that are being examined as a childhood obesity prevention strategy through two large cluster-randomized trials. This award will: 1) generate new research that will help adapt and translate these interventions to community settings, 2) provide rich training experiences in translational patient-oriented research, and 3) enhance Dr. Patel’s career development in research, leadership, and mentoring.